Innate immune triggers of alloantibody induction

PROJECT SUMMARY
Red blood cell (RBC) transfusion is a life-saving therapeutic tool and the most common form of allogeneic
transplantation in clinical practice. Despite ABO blood type matching, transfusion recipients can make
alloantibodies against non-ABO polymorphic RBC antigens. Such antibodies can result in significant morbidity
and even mortality, due to difficulty locating compatible RBC units, hemolytic transfusion reactions, or hemolytic
disease of the fetus and newborn. The burden of alloimmunization is high in patients requiring life-long chronic
transfusion therapy, such as those with sickle cell disease. Despite its medical importance, little is known about
what makes transfused RBCs capable of activating the immune system in order to generate alloantibodies. Using
a pre-clinical model, we discovered that mouse RBCs, after processing and storage in conditions that replicate
clinically used methods and storage solutions, activate splenic dendritic cells (DCs) in the spleen of transfusion
recipients. We further showed that activation of these DCs is required for alloimmunization by initiating CD4+ T
cell priming. DC activation does not occur if fresh RBCs (without storage but identical processing) are transfused.
Further, DC activation occurs even when stored RBCs lack an alloantigen. This led us to search for how stored
RBCs trigger innate immune receptors after transfusion. By testing numerous families of pattern recognition
receptors, we discovered that RBC alloimmunization requires the Toll-like receptor (TLR) signaling adaptor
molecule MyD88. MyD88 has also been implicated in the alloimmune responses in solid organ transplantation
by activating DCs for T cell priming; however, the nature of the ligands or the TLR relevant for graft rejection in
these systems remains unknown.
Using cell type specific MyD88 deletion, we found that DC and B cell, but not macrophage intrinsic MyD88
signaling is required to mount an alloantibody response. We ruled out a requirement for most MyD88 dependent
cytokine pathways in RBC alloimmunization; instead, our preliminary data suggest that particular TLRs are
necessary for the response to RBCs. Given the sterility of RBC units used for transfusion in patients and animal
models, we hypothesize that mammalian damaged self-molecules adhere to RBCs either during storage or after
transfusion into the recipient and trigger TLRs on B cells and DCs to induce alloimmunization. To test this
hypothesis, we will identify the immunostimulatory ligands on stored RBCs that are responsible for initiating the
alloantibody response. Our preliminary data using screening TLR cell reporter assays support that human RBCs
can activate select TLRs in vitro. We will determine TLR-dependent activation pathways in DCs and B cells
necessary for alloimmunization and will trial validated TLR inhibitors to see if we can avert alloimmunization in
our mouse model. Successful identification of RBC-derived TLR triggers would enable screening of RBCs with
immunostimulatory potential, as well as identifying new therapeutic targets to mitigate RBC alloimmunization.

Public health relevance
PROJECT NARRATIVE Red blood cell (RBC) transfusion is a powerful therapeutic tool and the most common form of transplantation in clinical practice, yet the immune system of the transfusion recipient can respond to these foreign RBCs and cause harm through antibody production. We have developed a mouse model of RBC transfusion to identify the early signals that trigger the immune system to respond to donor RBCs. Such an understanding is an important step towards developing targeted therapies to block this detrimental immune response, especially in those who require lifelong RBC transfusion support such as those with sickle cell disease.